Proteomics Resource

The Stanford Proteomic Shared Resource is a state-of-the-art proteomics facility dedicated to providing rapid and low-cost support for proteomic methods to Stanford Cancer Center investigators. Services include protein purification, peptide and protein identification, and analytical characterization of modifications and other small compounds. The Shared Resource has the necessary scientific and technical foundation, as well as a clean physical plant to conduct high accuracy mass spectrometry. Substantial cost savings, efficiency, and scientific advancement is provided by this type of centralized facility. An advisory board provides recommendations on facility policies and activities, ensuring that this Shared Resource is aligned with the Cancer Center's strategic goals. In fiscal year 2005, the Proteomics Shared Resource has performed close to 600 proteomic analyses for 30 different laboratories, including 18 members of the Cancer Center, representing 6 of the 10 Cancer Center Programs. Use in fiscal year 2005 reflected an increase of 60% as compared to 2004. Future plans for the Shared Resource include expansion of capacity and capabilities with new mass spectrometers, an ongoing effort in improved and novel analysis software, and development of chromatographic strategies.